The processes through which prostate cancer survivors and their partners adopt and maintain a healthy diet during prostate cancer survivorship

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
ABSTRACT
The number of men living with and beyond a prostate cancer (PCa) diagnosis exceeds 3.3 million and is rapidly increasing in the United States. An estimated 30% of PCa survivors develop comorbid conditions (e.g., hypertension, heart diseases, and stroke). Comorbidity is the leading cause of mortality for PCa survivors, surpassing mortality caused by PCa itself. A healthy diet protects survivors from comorbidities and improves PCa survival outcomes, yet few PCa survivors adhere to a healthy diet. Moreover, PCa is often considered a “couple’s disease,” as in both survivors and their partners (i.e., spouses or cohabiting partners) perceive the threats of PCa to their health and life, which may, in turn, increase their receptivity to adopting a healthy diet. Within an intimate relationship, it is likely that one’s diet is influenced by both self-perceived and partner-perceived threats. However, these interdependent relationships have not been examined among PCa survivor and partner dyads. Furthermore, the connection of perceived threats to diet may be influenced by factors at dyadic (e.g., relationship quality) and neighborhood (e.g., area deprivation index and food access) levels. In addition, after PCa survivors and partners perceive the threats of PCa, little is known about how they communicate and collaborate to adopt a healthy diet. To address these knowledge gaps, we propose a multi-method study to investigate the process through which PCa survivors and partners adopt and maintain a healthy diet during the PCa trajectory. Adopting the Actor-Partner Interdependence Model as the analytic model, in Aim 1 we will examine the interdependent relationships between perceived threats and diets and their changes over time. We will use data from 280 dyads of PCa survivors and partners in the Prostate Cancer Education & Resources for Couples (PERC) study (1R01NR016990-01A1). We will also assess how these relationships are moderated by dyadic relationship and neighborhood conditions. For Aim 2 we will recruit 20 dyads of PCa survivors and partners at the University of North Carolina Medical Center and conduct dyadic interviews supplemented with one-to-one interviews to determine how they communicate and collaborate to adopt and maintain a healthy diet. This study aligns with the research lenses of prevention and health promotion in NINR’s 2022-2026 strategic plan. This proposed study, combined with the training plans for career development, serves as my initial step towards becoming an independent behavioral and nurse scientist to develop and test couple-based behavioral interventions for cancer survivors and partners.

Public health relevance
PROJECT NARRATIVE A healthy diet has the potential to improve health outcomes and quality of life for prostate cancer (PCa) survivors and their partners. We will investigate how PCa survivors and their partners adopt and maintain a healthy diet within the context of their dyadic relationship and neighborhood conditions. This award will accelerate my development as an independent behavioral and nurse scientist dedicated to identifying couple-focused strategies to support cancer survivors and partners to adopt and maintain healthy lifestyle behaviors.